EPIDURAL CLONIDINE FOR THE TREATMENT OF PAIN ASSOCIATED WITH ADVANCED CANCER

Clonidin, an alpha adrenergic agonist, can provide significant pain relief particularly for neuropathic pain in patients with severe pain from malignancies.